Next-Day Effects of Binge Drinking on Inhibitory Control in Laboratory and Naturalistic Settings

Project Summary/Abstract
Binge drinking occurs at an alarmingly high rate, despite its negative consequences on behavior, health, and
cognition. One acute cognitive consequence of binge drinking is the impairment of inhibitory control, or the
ability to stop oneself from engaging in maladaptive or inappropriate behaviors. Specifically, during a binge
episode, individuals display impaired inhibitory control while completing Go/NoGo or Stop Signal Tasks (SST).
This impairment has been shown to be maintained for up to five hours post-drinking, even as breath alcohol
concentration (BrAC) approaches zero. Evidence also suggests that binge drinking results in next-day deficits
in attention, memory, and psychomotor speed. However, no study to date has assessed the next-day effects of
binge drinking on inhibitory control. The objective of this proposal is to determine the influence of binge
drinking on next-day inhibitory control. This objective will be addressed through two specific aims: 1) to
determine the next-day effects of binge drinking on inhibitory control in a laboratory setting, and 2) to determine
the next-day effects of binge drinking on inhibitory control in a real-world setting. For Aim 1, frequent binge
drinkers will come to the laboratory for two sessions in which they will complete the SST to assess inhibitory
control during a 90-minute intravenous infusion of either saline or a binge-equivalent dose of alcohol (peak
BrAC of 100mg%) in a counterbalanced manner. Then, participants will spend the night in the laboratory under
strict observation and complete the SST again the following morning (9 hours post-infusion) when BrAC is at or
near zero. For Aim 2, the same participants from Aim 1 will complete the SST from home and answer
questions about their previous day alcohol consumption every morning for 30 days. It is hypothesized that, for
both aims, a prior evening binge episode will result in next-day impairments in inhibitory control relative to
mornings in which no alcohol was consumed the evening prior. Completion of this research plan, in conjunction
with mentored-directed training, coursework, and workshops, will provide training in three critical areas: 1)
laboratory alcohol and cognitive research; 2) naturalistic alcohol and cognitive research; and 3) multilevel
statistical modeling and multiple imputation. Results from these studies will lay the foundation for future
research evaluating how next-day cognitive impairments from binge drinking influence subsequent drinking
and risk-taking behaviors. The proposed training plan will provide crucial skills needed to continue this line of
research focused on the cognitive and behavioral consequences of binge drinking.

Public health relevance
This project is part of a research program designed to address gaps in our understanding of how binge drinking influences subsequent cognition and behavior. Impaired inhibitory control the day after a binge episode could influence both subsequent drinking behaviors and risky behaviors in general. Evaluating this understudied post-drinking period could reveal crucial information about cognition and behavior which can be incorporated into existing AUD prevention and treatment efforts.